UT MD Anderson Cancer Center Network Lead Academic Participating Site (LAPS) UG1

PROJECT SUMMARY
Clinical trials are an integral part of MD Anderson Cancer Center’s (MDACC) mission. In FY2023, we cared for
approximately 179,000 patients and enrolled more than 9,600 patients on nearly 1,500 interventional studies.
MDACC has made significant contributions to the former NCI cooperative groups and the new National Clinical
Trial Network (NCTN), including robust trial enrollment, scientific and administrative leadership, and mentoring
early career faculty to participate in these important national trials. For FY 2019-2024, at MDACC, 1429 patients
were enrolled in NCTN Network group clinical trials, including 1081 patients in therapeutic treatment trials
resulting in an average of > 200 patients per year. Centralized coordination of NCTN activities at our institution
has facilitated the development and conduct of multidisciplinary, innovative trials. This participation has led to
opportunities for service through various NCTN leadership roles. Our institution has also sponsored talented
clinical and translational investigators to apply for NCTN membership, provided mentorship of early career
faculty, and encouraged applications for NCTN peer-reviewed grant funding. These activities have contributed
to the success of the NCTN LAPS UG1 grant as well as working towards the fulfillment of our mission of
eliminating cancer in Texas, nationally, and globally through advances in cancer treatment, research and
education. Our goals will continue with the supplement request of the NCTN LAPS UG1 grant.

Public health relevance
PROJECT NARRATIVE In FY23, with clinical trials being an integral part of MDACC’s mission, we were able to treat more than 9,600 patients on approximately 1,500 interventional trials making significate contributions to the National Clinical Trial Network (NCTN). Not only were we able to enroll more than 200 patients per year, but we were also able to provide robust trial enrollment, scientific and administrative leadership, and mentorship of early career faculty to participate in these important national trials. With the supplement request of the NCTN LAPS UG1 grant, we will continue working towards our mission of eliminating cancer in Texas, nationally, and globally.